NIMHD SCHARE RESEARCH PLATFORM:SCHARE-TERRA-GDE

ScHARe platform data ecosystem framework focused on Population Science, SDoH, Behavioral, Environmental Data is built. Funds would be used to make user-friendly enhancements, including drag and drop tools for novice users; to develop functionality enhancements to foster better data integration, and visualization Funds would support the mapping of Common Data Elements
from projects into the ScHARe repository to increase data harmonization and interoperability of projects including SDoH. Funds
would support the linkage of DOIs and datacite into the repository for data annotation and sharing. Funds would support the
terra platform, ai-readiness, bias mitigation strategies and educational efforts of the think-a-thons (TaT) and collaborations with
AIM-AHEAD training and shared resources. TaT include underrepresented communities; thereby, enhancing community
engagement in cloud computing resources. These participants are prepped to move from TaTs into AIM-AHEAD fellowships and
programs.